Washington University Institute of Clinical and Translational Sciences (KL2)

I. Institutional Career Development Core (KL2), 7. Project Summary/Abstract:
The goal of the Washington University (WU) KL2 Career Development Program is to provide team-oriented,
competency-based, multidisciplinary mentored research training, didactic coursework, and professional
development for junior faculty. Our Clinical ResearchTraining Center (CRTC) provides educational resources
and infrastructure for the WU Institute of Clinical and Translational Science (ICTS) and partner institutions.
We are requesting 9 KL2 slots to support junior faculty for 2-3 years. To enhance our successful KL2, we will
develop additional innovative coursework, training and career development programs across the full
spectrum of T1-T4 research, emphasizing informatics and data science, health equity and implementation for
impact. To address the regional and national CTSA goals, we propose the following specific aims:
1: Enhance the CRTC and KL2 infrastructure and programs to provide personalized, competency-
based, rigorous, high-impact clinical/translational research training and skills. We will develop and
provide new curricula and training programs emphasizing implementation science for impact and equity. We
will enhance our hybrid and online courses to improve access and flexibility for trainees and share materials
with ICTS partners and other CTSA hubs. (CTSA Goal:Translational Workforce Development)
2: Provide high-quality, informatics training. We will enhance our informatics and data science training
(workshops, seminars, courses, certificates, and degrees), and integrate new informatics methods, tools and
skills into our courses and training programs to meet individual scholar needs. (CTSA Goal: Informatics)
3: Expand the number and diversity of investigators leading high-impact, multidisciplinary,
clinical/translational research teams. We will train scholars, faculty and mentors from diverse disciplines and
promote recruitment and retention of faculty and scholars from under-represented in medicine (URiM) groups.
To expand high-impact research in diverse communities and populations across the lifespan, we will integrate
new team-science, URiM focused mentoring and leadership development into our courses and career
development programs (CTSA Goals: Integrating Special Populations across the Lifespan)
4: Increase collaborations between the faculty, mentors, and scholars in the KL2 program and
stakeholders, ICTS program functions, partners, and CTSA hubs. We will create new resources, share
best practices, and advance diverse interdisciplinary scientific teams to foster patient and community engaged
research and training at local, regional, and national levels. (CTSA Goal: Collaboration and Engagement)
5: Demonstrate the impact of the KL2 program. We will assess the short- and long-term performance of
scholars, determine the efficacy of training methods, and use this data to improve training, trainee and faculty
satisfaction, mentoring, diversity, leadership and outcomes. (CTSA Goal: Methods and Processes)